UMB Admin Core

Administrative Core – Abstract
This Program Project Grant (PPG) entitled Harnessing a Two-State FEP LHS to Optimize Engagement and Prevent
Disengagement in CSC is supported by an Administrative Core to provide resources and maintain the communication
needed to coordinate the research and financial activities being conducted in the five institutions – the University of
Maryland, the University of Pennsylvania, Johns Hopkins University, the University of Pittsburgh, and Sheppard Pratt
Healthcare – that are participating in this research. The Administrative Core is directed by Drs. Melanie Bennett and
Monica Calkins. The Administrative Core is located at the University of Maryland School of Medicine in the Department
of Psychiatry, Division of Psychiatric Services Research. The focus of the Administrative Core is the successful
implementation of the program goals to support a coordinated research program focused on optimizing Coordinated
Specialty Care (CSC) engagement and preventing disengagement in youth with first episode psychosis (FEP).The
Administrative Core is integral to the overall goals of this PPG, particularly regarding synergy among projects. The AC
and the Research Projects are highly inter-related and each interacts with the others. The Administrative Core will
maintain a stable, flexible, yet centralized infrastructure to promote and coordinate multi-disciplinary research in
promoting engagement involving experts in psychiatric services research, interventions development and
implementation in psychosis, cognition and cognitive assessment, clinical trials, implementation science, and
participatory research. The leadership team and administrative support described herein has proven to be very effective
and flexible working together during the current Early Psychosis Intervention Network (EPINET) project (MH120550).